Molecular Transducers of Physical Activity and Health: NC Consortium Clinical Site

MoTrPAC Project Summary
The Molecular Transducers of Physical Activity Consortium (MoTrPAC) is designed to discover and
characterize the range of molecular transducers underlying the effects of exercise in humans. MoTrPAC was
launched in 2016 with six adult clinical centers and a pediatric center that have collaborated to generate
extensive Manual of Operations to guide research protocols involving all aspects of the clinical operations
(Phase I). Phase II began in the fall of 2019 with all human clinical centers showing excellent progress towards
initial recruitment goals and implementation of the protocol. The initial goal set forth by NIH was to recruit 270
children (10-17 years of age) and 1980 sedentary adults (age 18 years or greater) randomized to endurance
training (170 youth, 840 adults), resistance training (840 adults), or non-exercise controls (50 youth, 300 adults).
An additional group of highly active endurance (50 youth, 150 adults) and resistance (150 adults) trained
individuals serve as comparators, not participating in the MoTrPAC exercise training programs. The recruitment
and enrollment approach are sex-balanced, with participants across a wide range of ages (10-17, 18-39, 40-59
and >60-year age groups) and of different races. Due to the COVID-19 pandemic, beginning in March 2020,
MoTrPAC activities were suspended for over a year with continued constraints through 2022. Despite the
numerous challenges encountered as a result of the pandemic, the human clinical centers have successfully
enrolled ~80% (adult) and 95% (pediatric) of the highly active cohort, ~93% of cross-sectional (pediatric), and
~60% (adult) and ~50% (pediatric) of the current target enrollment numbers in the randomized control trial
portion of the study. This will enrich the participant cohorts that are critical to the understanding of exercise
adaptations and heterogeneity across age, gender, and minority groups. Altogether, this supplement will allow
MoTrPAC to complete the intended goals as originally envisioned, will provide a more complete public
database of the health benefits of exercise, and will provide insight into how physical activity mitigates disease
risk. The purpose of the supplement, which was previously discussed with Program Officer ,will be to
assemble, curate andwill be to assemble, curate and harmonize the cardiopulmonary exercise testing (CPET)
database.

Public health relevance
MoTrPAC Narrative While there are many important health benefits of physical activity, how exercise exerts its effects is not fully understood. A more comprehensive understanding of the molecular mechanisms underlying the responses to exercise would significantly impact public health. Continuation of the Molecular Transducers of Physical Activity Consortium (MoTrPAC) will achieve its objective of generating a comprehensive map of the molecular responses to acute exercise and exercise training with the long-range goal of elucidating the mechanisms by which exercise improves healt, while assembly of the definitive MoTrPAC CPET database will give confidence of the human physiologic data to be paired with the molecular data and be the largest physiologic database of its kind for use by the exercise research community.